TRAINING IN CANCER AND CANCER RELATED RESEARCH

The goal of this training program is to provide in-depth and intensive research and didactic instruction in the molecular and cellular biology of cancer for highly qualified and committed predoctoral and postdoctoral students, with the intent to train future cancer research scientists. The program faculty includes many well-established investigators who have active, peer-reviewed research support which meets NCI "referral guidelines". In addition, all the preceptors have both an active publication record and a successful training record. Predoctoral students will receive didactic instruction designed to develop a thorough understanding of molecular and cellular biology as it pertains to cancer initiation, progression and prevention. Predoctoral and postdoctoral students will receive extensive laboratory training employing state of the art methodologies to study neoplasia at the molecular and cellular level. All trainees will be required to take courses and participate in programs to provide the trainee with an overview of the clinical aspects of cancer, including information on detection, treatment, prognosis, therapy, prevention and control, as well as opportunities in translation research. Programs will be implemented to expose the trainee to the realities of cancer patient treatment and care. Instructional programs are provided to expand the scientific communication skills of the trainees. Lastly, an intensive program is included foster awareness of the trainees' inherent responsibilities to undertake their studies with the highest level of ethics and integrity. Through this program, predoctoral and postdoctoral students will be prepared to pursue careers in the study of the molecular and cellular biology of neoplasia, with a broad perspective of the cancer problem.